SURVEILLANCE SUPPORT SERVICES FOR THE NATIONAL CANCER INSTITUTE

Surveillance Support Services for the National Cancer Institute The purpose of this contract is to provide national and local survey research with probability samples and support to the NCI in a variety of cancer control surveillance activities.